REGULATION OF HEPATIC METABOLISM BY INSULIN

The aims of the proposd work are to investigate the roles of covalent enzyme phosphorylation of hepatic lipogenesis and the activity of the key rate-limiting enzyme of fatty acid synthesis, acetyl-CoA carboxylase. Particular emphasis is being placed on the characterization of site-specific phosphorylation changes in the enzyme indued by hormones in the intact cell and the characterization in vitro of the major site-specific protein kinases and phosphatases responsible for these alterations. In addition, the regulation of hepatic lipogenesis by insulin is being employed as a model system for the further elucidation of the molecular mechanism of insulin action..